Small Compound Inhibitors Targeting HPV Genome Replication

Abstract
Human papillomavirus (HPV) is the causative agent for cervical cancer and is etiologically linked to penile
cancer, anal cancer, and oral cancers induced through sexual contact with HPV-infected individuals. Although
three prophylactic vaccines that prevent up to nine types of HPV infection (Gardasil 9 for types 6, 11, 16, 18, 31,
33, 45, 52 and 58) are available and recommended for vaccination of adolescent girls/boys and adults up to age
45, vaccine hesitance and lack of therapeutics have made it difficult to eradicate this highly infectious human
pathogen. As such, there is an urgent need to develop therapeutic agents able to block HPV propagation during
early-stage viral episomal replication and late-stage HPV integration-perturbed host transcription programs.
In our effort to identify cellular targets potentiating HPV-associated cervical and head-and-neck cancers, we
found a chromatin-binding factor, bromodomain-containing protein 4 (BRD4), plays a crucial role in HPV DNA
replication, genome segregation, viral gene regulation, and induction of cellular apoptosis and senescence
through physical and functional association with HPV-encoded early protein 2 (E2). Besides being an emerging
cancer therapeutic target, BRD4 is also a promising target for antiviral development. To understand the
molecular basis of BRD4-dependent HPV replication, we knocked down BRD4 in cultured human C-33A cervical
cancer cells and found that replication of high-risk HPV16 was completely abolished with no detectable origin of
replication activity. Intriguingly, loss of HPV16 origin replication could be efficiently rescued by introducing wild-
type, but not a phosphorylation-defective mutant, BRD4 back into the BRD4-knockdown cells. This finding
suggests pharmacological inhibitors and stimulators regulating the extent of BRD4 phosphorylation and small
compounds that target this phospho region of BRD4 are promising agents capable of blocking HPV replication
and thus inhibiting HPV propagation in infected host cells. In this proposal, we will test the hypothesis that
compounds targeting the phospho sites in a low-complexity intrinsically disordered region of BRD4 are potent
inhibitors of HPV genome replication. The aims are:
1. Identify compounds effectively inhibiting HPV genome replication
2. Define the mechanistic action of phospho-BRD4-targeting compounds
Three dozen or so compounds that we identified from a 200,000-chemical library screening, along with their
newly derived analogs, will be analyzed for their ability to inhibit the three stages (establishment, maintenance,
and amplification) of HPV DNA replication with promising compounds further examined for their
pharmacokinetics, in vivo toxicology, and mechanistic action in inhibiting HPV life cycle. This new class of
phospho-BRD4-binding compounds as target-selective protein-protein interaction inhibitors, unlike pan-
bromodomain inhibitors (e.g., JQ1 and I-BET) that non-selectively inhibit BRD4 chromatin association, provides
a new line of research for developing anti-HPV agents for treating populations already infected by HPVs.

Public health relevance
Project Narrative (Public Health Relevance Statement) Human papillomaviruses (HPVs) induce cervical cancer, penile cancer, oral cancer, genital warts, skin warts, and many other human diseases. Although three prophylactic HPV vaccines are presently available for preventing HPV infection in young girls and boys and adults up to 45 years old, therapeutic agents that are most needed for HPV- infected individuals are still lacking. The research described in this proposal will unravel the roles of viral and cellular proteins involved in HPV genome replication and facilitate future development of drug inhibitors able to block HPV propagation and oncogene expression in HPV-associated cancer.